LONGITUDINAL STUDY OF A PRE-OSTEOPOROSIS POPULATION

This project consists of a longitudinal, prospective study of the population-at-risk for osteoporosis. Research subjects are 184 normal women who were aged 35-45 at the start of the study in 1967. Observations are made once every five years and consist of comprehensive calcium kinetic, calcium metabolic, and physiological measurements, as well as radiogrammetric and photon-densitometric measurement of bone mass. A total of well over 120 primary and derived variables are accumulated on each subject. The plan is to continue these observations until a sufficient fraction of the study population develops vertebral crush or other osteoporosis-related fractures. At the onset of the new project period the study population will be in the age-range 53-63, and we anticipate beginning to see osteoporosis-related fractures developing during this next five-year period. The purposes of the project are: 1) to obtain comprehensive longitudinal data on various measures of calcium metabolism, bone metabolism, and related physiological functions in a group of untreated women from the perimenopausal period to the median onset time of osteoporotic symptoms; 2) to provide an exhaustive physiological profile both on women who develop symptomatic osteoporosis, and on those who do not, thereby allowing prospective characterization of the differences between them and of the factors influencing those differences; 3) to permit better identification of the osteoporosis-prone subset and thereby to provide both a rational basis for prophylactic treatment and the identification of subjects who should be its target; 4) to characterize cross-sectional inter-relationships between major physiological variables during this key era of osteoporosis development; and finally 5) to provide a comprehensive database for testing hypotheses about associations among variables developed by us and others outside the context of this protocol.